CTSA Predoctoral T32 at University of Colorado Denver

Project Summary/Abstract
The Colorado Clinical and Translational Sciences Institute’s (CCTSI) T32 Pre-Doctoral Training Program
aligns and supports the goals of NCATS to ensure that a diverse pool of highly trained scientists is available in
adequate numbers and in appropriate research areas to carry out the nation’s clinical and translational science
research (CTSR) agenda. Our proposed Team Oriented Training across the Translational Sciences
Spectrum (TOTTS) program will support trainees’ competency development and foster characteristic
development for translational research scientists. We request 8 slots for diverse trainees that represent the
translational spectrum (biomedical/bioengineering PhD students, population health/health outcomes PhD
students, clinician doctoral students) to complete our 2-year program, with clinician doctoral students having a
1-year option. Our overall goal is to meet the needs of the translational science and research community by
preparing diverse interdisciplinary doctoral trainees that are team oriented and have developed characteristics
and associated skills necessary for successful CTSR careers, including Domain Expert, Rigorous Researcher,
Boundary Crosser, Process Innovator, Team Player, Skilled Communicator, and Systems Thinker. Our
program’s value is that Diversity Accelerates Research and Translation (DART). Integration into the clinical
and translational fabric strengthens a person’s connection, self-efficacy, and identity formation, thus increasing
the likelihood that T32 trainees remain in the translational workforce. Our program’s curriculum and
approaches are based on our colleague’s conceptual framework for diversifying the CTSR workforce, Model
for Persistence of a Diverse Clinical and Translational Research Workforce. A program objective is to
apply evidence informed mentoring practices to support developing trainees from all backgrounds for
career persistence and success in CTSR. Evidence informed practices to be applied include 1) signed
mentoring agreements, 2) development and regular review of Individualized Career Development Plans, 3)
completion of Mentoring3: Mentor, Mentee and Peer, an effective mentoring training program attended by both
mentors and mentees, 4) annual mentor-mentee dyad reviews with feedback, and 5) trainee Mentoring
Advisory Team reviews. Several programmatic elements are novel to promote skills development and
successful transitions into careers as translational scientists: translational mentor supported immersion
experiences (clinical, industry, community, lab), Leading and Teaming, Writing Accountability Groups, F-Grant
Review and Mock Study Section, Communicating Research to the Public, and Café Scientifiques. Evaluative
emphasis will be placed on our ability to achieve our goal of attracting and supporting the training and
persistence of individuals from diverse (especially underrepresented) backgrounds who have the potential to
infuse CTSR with new perspectives and approaches that are efficient and effective.

Public health relevance
Project Narrative The Colorado Clinical and Translational Sciences Institute’s (CCTSI) T32 Pre-Doctoral Training Program aligns and supports the goals of NCATS to ensure that a diverse pool of highly trained scientists is available in adequate numbers and in appropriate research areas to carry out the nation’s clinical and translational science research agenda. Our proposed Team Oriented Training across the Translational Sciences Spectrum (TOTTS) program will support pre-doctoral trainees’ (biomedical/bioengineering PhD students, population health/health outcomes PhD students, clinician doctoral students) competency development and foster characteristic development for translational research scientists. Evaluation will focus on our ability to achieve program objectives and goals of attracting and supporting the training and persistence in the field of individuals from diverse (especially underrepresented) backgrounds that have the potential to infuse clinical translational science and research with new perspectives and approaches that are efficient and effective.